Role of frataxin in liver injury

PROJECT SUMMARY
Metabolic dysfunction-associated steatotic liver disease (MASLD), a spectrum of liver diseases from simple
steatosis to, steatohepatitis, hepatic fibrosis, and cirrhosis, is the most common liver disease in the United States
and worldwide. There are currently limited treatment options for MASLD because of our poor understanding of
its pathogenesis. Dysfunction of the mitochondria induces disrupted lipid metabolism, oxidative stress, and
hepatocyte death. While compelling evidence indicates a central role of mitochondrial dysfunction in the
development and progression of MASLD, the underlying cause of mitochondrial dysfunction remains elusive.
Iron is essential for cell metabolism dependent on the biogenesis of iron sulfur clusters (ISCs) and heme,
essential cofactors for enzymes in the citric acid cycle and mitochondrial respiration chain. Impaired iron
utilization, as seen in Friedrich’s ataxia (FRDA) due to the loss-of-function of mutations in frataxin (FXN), leads
to ISC deficiency and mitochondrial free iron overload (MFIO). Nevertheless, the potential role of FXN has never
been examined in metabolic diseases including the MASLD. Our preliminary study identified for the first time a
markedly decreased expression of FXN in mouse and human specimens of MASLD. We have also observed
hepatic MFIO and ferroptosis in a chronic mouse model of MASLD. Additional data showed a protective role of
FXN against liver injury in an acute model of MASLD. We therefore hypothesize that steatosis-induced
downregulation of FXN disrupts mitochondrial function and lipid metabolism and induces MFIO-dependent
hepatocyte ferroptosis, which collectively promote the development of steatohepatitis. Specific Aim 1 will
interrogate whether FXN deficiency induces while restoration of FXN expression prevents ferroptosis-mediated
liver injury related to MASLD. We also aim to unravel a ferroptosis-specific mechanism that triggers liver
inflammatory responses. Specific Aim 2 will determine the precise mechanism by which MFIO triggers lipid
peroxidation in the plasma membrane ultimately leading to ferroptosis, with a focus on labile iron dynamics
through real-time confocal fluorescence imaging. Specific Aim 3 will identify the critical role of steatosis-
associated ER stress response in the induction of hepatic FXN protein degradation in mice and humans with
MASLD. A temporospatial changes in FXN expression at the different disease phases of MASLD will be also
determined. Successful completion of the proposed studies will unveil that FXN-dependent defects in
mitochondrial iron metabolism is a novel mechanism of mitochondrial dysfunction and ferroptosis-mediated liver
injury in MASLD, laying the foundation for developing potential new therapies.

Public health relevance
Project Narrative Oxidative damage and death of the hepatocytes is an important cause of liver injury and the progression of MASLD. We have identified that defective expression of frataxin induces mitochondrial free iron overload that in turn mediates oxidative damage and ferroptotic death of the hepatocytes. The objective of this proposal is to unravel how frataxin deficiency induces liver injury and hepatic inflammation and further define the mechanism of frataxin downregulation in MASLD.